STANDARD ENUCLEATION VS ENUCLEATION AFTER EXTERNAL RADIATION FOR LARGE TUMOR

This is a multicenter, 10yr, prospective study of choroidal melanoma patients to determine 1) if I125 plaque treatment is superior to enucleation for medium tumors in prolonging life, 2) if external beam treatment given before enucleation is superior to enucleation alone in large tumors in prolonging life.